Cognitive Outcome Measures in School Age Children with Down Syndrome

PROJECT SUMMARY
There is a fundamental gap in the availability of cognitive outcome measures that are reliable and sensitive to
detecting change among children with Down syndrome (DS). Lack of such outcome measures represents an
important problem to interpreting clinical trials aimed at improving the lives of individuals with DS. Without
evidence-based cognitive outcome measures, future treatment trials in this population will remain suboptimal
due to poor study measures. Despite some promising findings in currently recommended assessment
batteries, the evidence base for cognitive outcome measures in DS is limited. Multi-site studies evaluating the
reliability and validity of outcome measures are the needed next step towards supporting the evaluation of new
pharmaceutical and clinical interventions for children with DS. Working groups convened by NICHD of leading
experts in DS led to recommendations of promising measures for use in this population. The current study
proposes to evaluate the psychometric properties of recommended promising measures and expands upon
these recommendations by evaluating individual variability and accounting for the method of assessment
(verbal, nonverbal, computer, parent-report) to support our understanding of performance within a cognitive
domain. The overall objective of this application is to establish the psychometric properties of clinical outcome
measures in children with DS across the cognitive domains of executive functioning (inhibition, working
memory, set-shifting), learning and memory, and processing speed. Our rationale for working with this
population is that DS is associated with a distinct pattern of cognitive strengths and weaknesses related to their
neuroanatomy. Thus the selection of outcome measures to be evaluated needs to take into account the DS
behavioral phenotype. We propose three specific aims: 1) To examine the psychometric properties of
measures in the assessment battery with children with DS. 2) To evaluate differences in the psychometric
properties of the measures as a function of variations in demographics and medical comorbidities. 3) To
characterize the developmental trajectories of cognition and executive functioning. To achieve these aims, 160
children ages 6-17 years with DS will participate in repeated neuropsychological assessments with follow-up
evaluations at 2 weeks, 3 months, 6 months, and 1 year. Parents and teachers will complete ratings of
executive functioning, adaptive behavior and behavioral concerns. Our research team is uniquely positioned to
conduct this work, combining expertise in DS, neuropsychological assessment, medical conditions and
measurement evaluation. We anticipate that this measurement study will provide critical guidance for future
efficacy and effectiveness trials. Our goals are in line with NICHD PAR-16-216 research priority to assess the
reliability, validity and change over time of measures for use in clinical trials in ID, in this case specifically
targeted to DS. As our field continues to develop new pharmaceutical and clinical interventions, our project will
support this work and have an impact on the 400,000 individuals with DS living in the United States.

Public health relevance
PROJECT NARRATIVE The proposed project will establish the reliability and validity of a battery of cognitive outcome measures for school-age children with Down syndrome. Current clinical trials are plagued by the dearth of clinical outcome measures appropriate and sensitive for individuals with Down syndrome. As our field continues to develop new pharmaceutical and clinical interventions, our project will support this work and have an impact on the 400,000 individuals with Down syndrome living in the United States.